Spatial Mapping of Proteomic and Transcriptional Signatures in Kidney Disease

AKI and CKD are highly prevalent diseases that are associated with significant morbidity and mortality.
Unfortunately, there are not currently any specific treatments for either of these conditions. Both diseases
are caused by a range of underlying diseases and processes. AKI, for example, can result from
hemodynamic, toxic, infectious, and immune insults to the kidney. In both AKI and CKD, the diagnosis is
based on changes in the serum creatinine and albuminuria, but these tests do not discriminate among the
various etiologies of injury. Thus, beyond detecting a reduction in kidney function, clinicians typically have
little information regarding the underlying pathologic process. Better understanding of the cellular and
molecular patterns in the kidneys of patients with AKI and CKD will provide key insights into these diseases
and will lead to new diagnostic and therapeutic approaches. In recent years, multi-omics analyses have had
a major impact on our understanding of several fields, such as cancer biology, and have supported the
identification and development of new treatments. These same technologies could transform our
understanding of AKI and CKD, particularly when spatial resolution is complemented with proteomic and
transcriptomic cellular analyses. Although kidney biopsies are not usually performed in patients with AKI and
CKD, biopsy samples obtained through the Kidney Precision Medicine Project (KPMP) offer a valuable
opportunity to analyze kidney tissue using state-of-the-art high-dimensional multi-omic platforms. We
propose to utilize complementary spatial protein and RNA technologies to generate comprehensive tissue
atlases for AKI and CKD. We will pursue the following specific aims: Aim 1. Generate a kidney cellular map
via phenotypic and functional protein expression profiling. We will analyze biopsies using Multiplexed Ion
Beam Imaging (MIBI), which detects 40+ protein targets at single-cell resolution (250 nm) with tissue-specific
spatial information. Aim 2. Generate a kidney morphological map via phenotypic and functional gene
expression profiling. We will analyze biopsies using Visium Spatial Transcriptomics (ST), which provides the
whole transcriptome with morphological context. Aim 3. Generate an integrated cellular and molecular protein
and gene expression kidney atlas. We will apply statistical and bioinformatic approaches to integrate the
results from Aims 1 and 2 to create a composite map of the cellular protein and transcriptional expression
profiles in the kidney. To accomplish these goals, we have assembled a multidisciplinary research team that
includes nephrologists, renal pathologists, immunologists, and experts on multi-omics systems biology
analyses. The proposed experiments are expected to reveal subsets of AKI and CKD patients based on the
patterns of cells and molecular pathways present in the kidney, and to support identification of novel
candidate biomarkers and therapeutic targets.

Public health relevance
The proposed research is relevant to public health because acute kidney disease (AKI) and chronic kidney disease (CKD) are widespread problems that are both associated with significant morbidity and increased mortality. Currently, supportive care is the only therapeutic option for these diseases. The experiments in this proposal will improve our understanding of the mechanisms of AKI and CKD, and they may lead to effective new therapies.